The Role of IgE in Galectin-3-dependent Activation of Basophils

Project Summary
Immunoglobulin E (IgE) binds with high affinity to its receptor, FCeR1, found on the surface of basophils and
mast cells. When an antigen binds to receptor bound IgE, it can lead to IgE receptor cross-linking and
activation of basophils and mast cells. In this case, the antigen is subcategorized as an allergen. Thus, IgE is a
pivotal molecule in the initiation of allergic reaction in a wide range of tissue. The IgE-dependent activation of
basophils leads to the release of granular mediators and, also, to the production of Th2 inflammatory
cytokines, IL4/5/13. Recent work has revealed a novel, allergen independent mechanism by which IgE, bound
to its receptor, can lead to basophil activation resulting in greater IL4/13 production compared to standard IgE-
dependent activation. The mechanism of this allergen-independent activation involves the sugar-binding
protein Galectin-3 (Gal-3), which has been shown to bind directly to IgE. The data reveal that when a Gal-3
bearing cell physically comes into contact with a basophil, it leads to strong basophil activation. However, the
parameters of this interaction remain poorly defined. I hypothesize that Gal-3 interacts with IgE independently
of allergen specificity due to IgE’s variable glycosylation patterns, and that such glycosylation patterns may
differ between allergic and non-allergic subjects. IgE with more N-glycan sugars will interact better with Gal-3
while IgE with more sialic acid will not interact as well. My first aim is to compare Gal-3 with standard IgE-
dependent activation of basophils sensitized by serum from either allergic or non-allergic patients. My second
aim examines the hypothesis that the affinity of Gal-3 for IgE is based on the presence of N-glycan structures
and that this binding can be masked by terminal sialic acid residues. I will treat both whole cells and purified
IgE with glycan modifying enzymes and quantify the Gal-3-induced cytokine production in basophils. My
preliminary data shows that neuraminidase treatment, to remove terminal sialic acid residues, of whole
basophils primed with IL-3 and bearing IgE augments Th2 cytokine production when placed in co-culture with
Gal-3 bearing cells. The results of the study are expected to provide insight into a novel mechanism of allergen
independent IgE activation and should prompt investigation to correlate it with clinical relevance.

Public health relevance
Project Narrative This project centers on a novel mechanism by which basophils can be activated in an IgE-dependent, but allergen independent fashion. This has direct implications for the role of these cells in both allergic and nonallergic diseases.